Hereditary Genetics of Hepatocellular Carcinoma

Project Summary
Hepatocellular Carcinoma (HCC) is a devastating and prevalent cancer of the liver with high rates of mortality.
Major risk factors include chronic viral infection (hepatitis B or C), fatty liver disease, alcohol use, and exposure
to environmental toxins. An independent risk factor is a family history of HCC, which raises the risk by more than
2.5-fold. However, despite evidence of familial risk, the inherited component remains unknown. It also remains
unexplored whether inherited gene variants play a pathogenic role in HCC development, or whether they could
be used to guide treatment with targeted therapies. We have pioneered an investigation into inherited (i.e.
germline) genetic factors associated with HCC. We have completed a pilot analysis of 217 patients with HCC
prospectively enrolled from our medical center for clinical-grade multigene panel genetic testing. We have
captured details about their personal and family cancer history, risk factors, and outcomes. In our pilot analysis,
we found a surprisingly high rate of pathogenic germline variants in cancer-associated genes in patients with
HCC, including numerous pathogenic and likely pathogenic variants in genes required for homologous repair,
DNA damage response (HR-DDR). We hypothesize that inherited loss-of-function variants in specific genes are
enriched in HCC, and that carriers can be treated with targeted therapies. In Aim 1, we will conduct genetic
association studies that are powered to detect clinically meaningful germline variants linked to HCC, and we will
examine predictors of hereditary cancer syndromes in HCC including age of onset and family history of cancer.
In Aim 2, we will explore the mechanism of HCC arising from defects in HR-DDR genes, and determine the
implications for targeted therapies. These innovative studies of the hereditary genetics of HCC have the potential
to personalize therapies for the subset of patients with hereditary cancer syndromes. We have assembled a
team of experts in HCC, hereditary genetics, and animal models to complete this investigation. This study has
the potential to impact on the care of patients with HCC in the US and worldwide.

Public health relevance
Project Narrative This project will examine the hereditary genetics of Hepatocellular Carcinoma (HCC), a devastating cancer of the liver with well-defined environmental risk factors, but with an undefined inherited genetic component. Here, we will complete a genetic association study to determine whether patients with HCC harbor rare inherited variants in genes at higher rates than in control populations, which could guide clinical recommendations for genetic testing. We will also determine whether inherited defects increase cancer cell susceptibility to specific drug therapies, which could change clinical practice and improve survival.